EVALUATING THE INTEGRATION OF CARDIOVASCULAR, RESPIRATORY, AND CEREBROVASCULAR STABILITY AND MATURATION AND THEIR EFFECT ON RESPIRATORY AND NEUROLOGIC MORBIDITY IN PRETERM INFANTS

PROJECT SUMMARY Not required for PA-18-591.

Public health relevance
PROJECT NARRATIVE Not required for PA-18-591.